Assessing the Role of Sex-Specific Genetic Drivers of Cerebrovascular Disease in the Alzheimer's Disease Brain

ABSTRACT
Alzheimer's disease (AD) disproportionately affects women, yet the underlying biological and genetic factors
contributing to this sex disparity remain poorly understood. This proposal addresses this critical gap by
focusing on the intricate interplay between sex-specific genetic factors, cerebrovascular disease (CVD), and
AD pathogenesis. Building on our groundbreaking research revealing sex-specific genetic associations in AD-
related endophenotypes, we aim to extend this paradigm to explore the role of genetics in the development
and progression of CVD within the AD-affected brain and to investigate whether or not these relationships
present in a sex-specific manner. Our research team, with expertise spanning statistical genetics, sex
differences in Alzheimer's and related dementias, neuropathology, and neuropsychiatry, will harness the vast
resources of the Alzheimer’s Disease Genetics Consortium and the Alzheimer’s Disease Sequencing Project.
With autopsy data from over 9,600 well-characterized participants, including measures of CVD, amyloid and
tau burden, and longitudinal cognitive scores, we are uniquely positioned to conduct the most extensive sex-
specific genome-wide analyses of CVD endophenotypes in the context of AD to date. The specific aims of this
proposal are threefold: [1] identify sex-specific genetic markers of autopsy measures of brain vessel disease
(i.e., atherosclerosis and arteriolosclerosis), [2] identify sex-specific genetic markers of autopsy measures of
vascular brain injury (i.e., macroscopic and microscopic infarction), and [3] characterize the degree to which
known genetic drivers of CVD affect cognitive decline in a sex-specific manner. The outcome of this project will
highlight new candidate pathways and begin the process of characterizing the mechanisms by which genetic
variation among males and females affects the risk of CVD and clinical symptoms of AD. It also holds the
promise of identifying novel therapeutic targets and of moving the field towards personalized interventions that
consider an individual’s sex and neuropathological presentation.

Public health relevance
NARRATIVE Two-thirds of Alzheimer’s disease (AD) cases are female, and three-fourths of AD cases present with concomitant cerebrovascular disease. The goal of this project is to illuminate the sex-specific genetic architecture of cerebrovascular disease in the context of the AD brain. Our work not only contributes to a deeper understanding of sex disparities but also offers critical insights into the complex relationship between AD and cerebrovascular disease, which is essential for effective therapeutic strategies.